Narrative-Based Cultural Humility Training to Ensure Affirming Care for Transgender and Gender Diverse Veterans Across Services: A Pilot Feasibility Study

Background: Nearly 20% of the adult transgender population has served in the United States military. The VA
values and prioritizes research that seeks to cultivate an affirming culture and exemplary care for transgender
and gender diverse (TGD) Veterans. This work is critical, given that TGD Veterans are 20 times more likely to
attempt suicide and experience vast mental health disparities compared with non-TGD Veterans.
Significance: While current VA research is examining health services utilization as well as barriers and
facilitators to care from the perspectives of TGD Veterans and VA healthcare providers, implementation of
Veteran-informed, evidence-based cultural competence trainings for VA providers is lacking.
Innovation and Impact: Identity Development Evolution and Sharing (IDEAS) is an innovative and effective
stigma reduction training for healthcare providers that involves showing a film rooted in TGD Veteran
narratives and engaging providers in a post-film, moderated conversation with a panel of TGD Veterans.
Literature suggests performance-based interventions are less likely to trigger cognitive resistance than other
training modalities, maximizing their ability to reach providers who may not otherwise seek out this training.
Specific Aims: In Aim 1 we evaluate the impact of IDEAS on VA mental health and primary care providers,
asking ‘What is the impact of IDEAS on provider stigma beliefs?’ In Aim 2 we evaluate IDEAS feasibility,
acceptability, and implementation in Indiana VAMC and CBOCs via provider, stakeholder, and TGD Veteran
feedback, asking: ‘What percentage of VA Primary Care and Mental Health providers attend IDEAS and
complete pre/post tests?’ We also examine whether VA providers, TGD Veterans, and service line managers
consider IDEAS feasible and acceptable and identify characteristics of the intervention and settings associated
with implementation success. Our secondary aim is to explore the feasibility and preliminary outcomes of a
nested data collection design for evaluating IDEAS’ impact on TGD patients by asking ‘What percentage of
TGD patients complete pre/post surveys regarding patient perceptions of provider cultural competence’ and
‘What percentage of matched pre-post surveys evaluate IDEAS-trained providers?’ Hypotheses: We anticipate
IDEAS will reduce providers’ stigma beliefs, meet feasibility and acceptability benchmarks, and that 30% of
TGD patients will complete surveys about perceived cultural competence of their providers.
Methodology: We will implement IDEAS for providers who see the most TGD patients – Primary Care and
Mental Health – maximizing engagement by offering it during existing meeting times. We will measure: 1)
pre/post provider stigma; 2) implementation success, barriers, and facilitators; and 3) feasibility of assessing
TGD patient experiences with IDEAS trained providers. Pre/post comparison of Acceptance and Action
Questionnaire – Stigma surveys will reflect impact on provider stigma. Lower scores on this validated and
reliable measure indicate greater psychological flexibility and reduced enacted stigma. Data will be analyzed
using appropriate statistical tests accounting for variance, normality, and correlation. Implementation success
will be evaluated with post-IDEAS validated quantitative measures of acceptability and feasibility AS WELL AS
REACH, and expanded via qualitative provider, clinic chief, and TGD veteran interviews to examine
implementation barriers/facilitators. To assess feasibility of collecting data from TGD patients of IDEAS-trained
providers we will conduct TGD patient surveys using common data set items that measure patient perceptions
of provider cultural competence pre/post IDEAS and track completion rates.
Next steps/Implementation: Accomplishing these specific aims will result in increased visibility of resources
to support TGD healthcare, effectiveness data related to healthcare provider stigma reduction, and
implementation and feasibility data to be used to design the implementation and evaluation of a future national
deployment of IDEAS to enhance care for TGD Veterans.

Public health relevance
Nearly 20% of the adult transgender and gender diverse (TGD) population has served in the United States military. TGD Veterans are at very high risk of adverse outcomes (e.g., suicide). This project seeks to decrease provider stigma and enhance understanding and knowledge of affirmative care practices to promote wellness and reduce health disparities among TGD Veterans. We will show a filmed theatrical performance rooted in TGD Veterans’ experiences during regularly scheduled meetings for mental health and primary care providers. The film will be followed by a panel discussion between providers and TGD Veterans. We will examine changes in provider stigma (before vs. after the event); providers’, clinic chiefs’, and TGD Veterans’ perspectives about program implementation; and feasibility of assessing TGD Veterans’ perceptions their patient experiences after providers have been trained with IDEAS.